SIMULATING MOLECULAR DYNAMICS INFLUENCE ON EPR OF SPIN PROBES

Using novel methods of directly simulating the effects of molecular dynamics on magnetic resonance spectra, EPR spectra of N14 TEMPOL spin probes generated over 1-250 GHz and Brownian rotational correlation times 10-11 to 10-5 seconds. Simulations are in good agreement with less versatile techniques. Both experimental (W-band) and simulated spectra confirm predictions that VHF-EPR at higher frequencies show greater sensitivity in the faster motional regime (i.e. less than 0.1 ns).